Blocking tumor progression in therapy-responsive RET aberration-associated cancer

The rearranged during transfection (RET) gene encodes a protein tyrosine kinase (PTK). RET aberrations
are found in various types of human cancer. Highly potent and selective RET protein tyrosine kinase inhibitors
(TKIs) are in the later stage of clinical development for precision cancer treatment. A lesson learned from the
previous experience is that the PTK-targeted cancer therapy often fails because of adaptive resistance evolved
from the drug-tolerant, residual tumors. Results of our preliminary studies indicate that the RET-targeted cancer
treatment is no exception to this rule. To prolong the suppression of tumors and the lives of patients, we must
eliminate the residual tumor cells, identify target mutations that cause drug resistance, find or develop drugs
effective against different drug-resistant mutants, and discover alternative signaling mechanisms that promote
tumor progression. The overall goal of this project is to improve the targeted therapy for RET aberration-
associated cancer. The objectives of this project are to map the landscape of drug-resistant RET kinase
mutations, identify drugs effective against mutant RET, determine the structures of RET kinase variants,
characterize the structural bases of interaction between RET and its inhibitors, and evaluate a method to
minimize the residual lung tumors. Specific Aim 1 is to identify and characterize RET mutations resistant to
selective RET TKIs in preclinical models and cancer patients, and find potential secondary drugs. Specific Aim
2 is to determine the crystal structures of drug-resistant RET mutant proteins and RET-inhibitor complexes.
Specific Aim 3 is to test RET mutant-sensitive TKIs in vivo and evaluate a method for reducing the residual
fibrotic stroma and the associated residual tumor cells. Taken together, this study will provide a RET mutation-
TKI toolkit for precision management of RET-aberrant cancers to maximize the benefit of RET-targeted cancer
therapy, lay the foundation for developing a continuous pipeline of mutant-effective RET TKIs, and find a method
to reduce the residual drug-tolerant tumors to delay tumor recurrence. The outcomes of this project will have
positive translational impact on prolonging the survival of patients with cancer.

Public health relevance
Drug resistance in targeted cancer therapy usually occurs in solid tumors. This project aims to identify the biological and structural bases of resistance to aid in the selection and development of a pipeline of drugs to delay the progression of tumors. This project is relevant to the mission of the National Cancer Institute because it will lead to longer survival of patients with cancer and an eventual cure for the disease.